Clinic-level implementation of mHealth to improve HIV viral suppression for patients with substance use disorders

PROJECT SUMMARY / ABSTRACT
In response to PAR-20-036: Getting to Zero: Understanding HIV Viral Suppression and Transmission in the
United States, we propose a hybrid type 2 effectiveness-implementation study that will evaluate an innovative
clinic-level intervention featuring an evidence-based mobile health (mHealth) application (CHESS) and peer-
driven social support. Within the infrastructure of a large HIV/AIDS Service Organization offering an integrated,
patient-centered model of care in Colorado, Missouri, Texas and Wisconsin, we will implement an mHealth
system designed to close information gaps, build intrinsic motivation, and develop behavioral skills needed for
sustained adherence to treatment. Peer support will be provided through activities delivered by patients
recruited and trained to serve as peer mentors. The mHealth system and peer mentoring will be integrated into
the existing care model, known as the HIV Medical Home. We hypothesize that the integrated intervention will
increase the proportion of patients with viral suppression and reduce missed clinic appointments by supporting
three needs: (1) It will facilitate real-time, community-based capture of data reflecting social and behavioral
determinants known to precede lapses in HIV care (e.g., housing and food insecurity, unhealthy alcohol or
drug use, or poor medication adherence); (2) It will improve engagement in care by increasing social
connectedness among patients, and between patients and peer mentors; and (3) It will support retention in
addiction treatment and mental health care that help maintain engagement in HIV care. Project Year 1 will be
devoted to planning and refinement of the intervention in close collaboration with organizational leaders and
people living with HIV who are members of the local communities. Beginning in Project Year 2, we will conduct
a stepped wedge cluster randomized trial of the intervention in seven clinics. We will leverage data collected
through the integrated electronic health record system serving all seven clinics to test intervention
effectiveness on viral suppression and retention in care. We also will conduct an implementation cost analysis
and cost-effectiveness analysis to inform future sustainment of the intervention model. The study builds on a
solid foundation of prior research demonstrating the promise of mHealth and peer strategies for enhancing
engagement in HIV and addiction treatment and care for other complex conditions. The findings from this
study, if successful, will contribute a new and innovative set of tools with high potential impact for improving
HIV viral suppression in multiple geographic settings.

Public health relevance
PROJECT NARRATIVE / PUBLIC HEALTH RELEVANCE People living with substance use disorders and people from racial and ethnic minority groups make up a disproportionate share of new HIV infections in the United States, and once diagnosed, they are less likely to achieve and maintain viral suppression. These disparities reflect complex social and structural determinants of health, which can be addressed by existing medical and social services only if they are accessible, culturally appropriate, and delivered to patients when and where they are needed. This project will test the effectiveness of a combination of strategies, including an evidence-based mobile health app and peer mentoring, that can be integrated into an HIV clinical practice to improve viral suppression and retention in care for vulnerable patients.